Discovery and development of novel glycine transporter-2 inhibitors for the treatment of neuropathic pain

It is estimated that 7–10% of the general population suffers from chronic neuropathic pain and associated
annual economic costs exceed $160 billion in the US. Current analgesics used to treat chronic neuropathic
pain lack efficacy, induce dose-limiting side effects or present a significant risk of tolerance and abuse. Thus,
the discovery of novel analgesics that provide meaningful pain relief with improved safety, tolerability and
reduced abuse potential remains an unmet medical need. Among the various mechanisms involved in
pathological pain, disinhibition of nociceptive signaling from the spinal cord to the higher CNS plays a critical
role. Indeed, we and others have shown that inhibitory glycinergic neurotransmission in the dorsal horn is
impaired in pathological pain states. Thus, it has been proposed that enhancing spinal glycinergic
neurotransmission could reduce nociceptor signaling and provide analgesia. Glycine transporter-2 (GlyT-2)
regulates extracellular glycine concentrations in the CNS and presents a highly attractive target to augment
impaired spinal inhibitory signaling. Indeed, GlyT-2 inhibitors have demonstrated efficacy in several rodent
models of acute and chronic pain. Recent studies suggest that either partial or reversible GlyT-2 inhibition
can potentially circumvent potential mechanism-based adverse effects and provide analgesics with a suitable
balance of efficacy and tolerability. We synthesized 60 bioactive lipid allosteric partial inhibitors exhibiting
varying degrees of potency and %maximal inhibition and our most potent compound of this class enhances
tonic glycinergic currents ex vivo in rat spinal cord slices without depleting presynaptic glycine reloading and
produces in vivo dose-dependent efficacy in PNL rats without adverse effects. Separately, we synthesized
18 novel GlyT-2 inhibitor hit compounds derived from ORG-25543 that exhibit reproducible variations in
reversibility and transport recovery using a washout assay protocol. From these two libraries, we propose
conducting a dual-pronged medicinal chemistry campaign to identify optimized compounds possessing
favorable potency, binding profiles and ADME characteristics suitable for measuring effects in spinal cord
slices and in vivo PK. Selected compounds will be screened in the rat PNL model to assess analgesic efficacy
and in behavioral models for dose-limiting effects and TI. Our proposal seeks support to optimize our hit
compounds to provide selective and orally bioavailable GlyT-2 inhibitors for further development and eventual
human clinical trials in neuropathic pain. The studies outlined in this proposal seek to conduct medicinal
chemistry optimization using a battery of primary, secondary, counter-screen, and ADMET assays to assess
potency, binding profile (%maximal inhibition, reversibility and mechanism of binding), selectivity and drug-
like properties (Specific Aim 1), and assess PK, preclinical analgesic efficacy and tolerability of advanced
compounds in animal models of neuropathic pain and motor behavior at different stages of compound
optimization (Specific Aim 2).

Public health relevance
Project Narrative It is estimated that 7–10% of the general population currently suffers from chronic pain with neuropathic characteristics and the associated annual health care and loss of productivity economic costs are over $160 billion in the US. This proposal aims to discover and develop potent, selective and orally bioavailable inhibitors of glycine transporter-2 (GlyT-2) with either partial or reversible binding characteristics. Such agents could provide safe and effective novel analgesics for the treatment of chronic neuropathic pain.